3D biomimetic lymph node engineered extracellular vesicles for understanding

Contact PD/PI: He, Mei
ABSTRACT
Understanding how immune-heterogeneity leverages cellular diversity to achieve the adaptivity and flexibility in
immune-responses is a core challenge that has not been well studied, largely due to the lack of a valid immunity
tissue model for investigation of cellular communications. Recent discovery of trafficking vesicles since 2013
Nobel Prize of Medicine shined the light on the new avenue for understanding long-distance, non-contact cellular
communications in modulating immunity. However, the study of such diverse and nano-sized vesicles, namely
exosomes, is extremely challenging, due to immense difficulties in differentiating dynamic and heterogeneous
vesicle populations presented in the in vivo system. Our research work addresses key technology gaps by
developing a series of tool sets, including high-efficient and high-throughput microfluidic approach for exosome
isolation, subtyping, molecular engineering and transfection, and nano-delivery. Recently, we observed that
molecular packaging of secreted exosomes is highly variable upon the change of cellular culture environment
as well as surrounding community. The in vitro investigations with 2D cell culture systems are incapable of
interpreting in vivo exosome immunity modulation mechanism. We hypothesize that a 3D biomimetic lymph node
tissue system could serve as the in vivo -like tissue model for effectively studying in vivo exosome molecular
packaging and secretion dynamics upon stimulations, for interconnecting exosomal cargoes with cellular level
responses. This five-year study will focus on three key challenges for precisely elucidating immune-modulation
at the molecular level via the exosome route: 1) Develop a 3D, programmable biomimetic lymph node tissue
foundry with well-defined immunological adaptations for mimicking in vivo immune tissue microenvironment; 2)
Develop a single cell single exosome study approach for highly sensitive detection and subtyping of single
exosome populations with dynamic and statistical significance for understanding immunity heterogeneity; 3)
Discover motifs that can selectively pack immuno-stimulating microRNAs, as well as the MHC-binding peptides
into exosomes for targeted immunity modulation, which can establish the interconnection of cargo internalization
with cellular level responses. The long-term goal is to advance our understanding in immunity regulation
heterogeneity and eventually be able to precisely programme immune responses at the molecular precision.
Page 6
Project Summary/Abstract

Public health relevance
Contact PD/PI: He, Mei PROJECT NARRATIVE Human Immunity are notoriously sensitive to their environment and heterogeneous, making them difficult to study outside of a living model or across species. To combat these challenges, developing a precisely controlled 3D living tissue model for mimicking in vivo immune responses is pressingly needed, which presents an emerging approach for developing personalized precision immunotherapy. Page 7 Project Narrative